CALCIUM SUPPLEMENTATION EFFECTS ON BONE IN ELDERLY MEN

The purpose of this study is to determine whether adding calcium to the diet prevents bone loss in men age 65 years and older. Healthy ambulatory men, 65+ years, with a daily calcium intake of <1000mg/day and normal femoral bone mineral density (range Z score between -0.5 and +1.0) were recruited for a 2-year double-masked, placebo-controlled study. Thus far, 84 men have been screened with 41 qualifying for the study. Currently, negotiations with Bethesda Naval Hospital are on-going to start a second study site. Recruitment of healthy elderly men has been slower than expected. As a result, further expansion of this study to other sites is under investigation.